Identification of Molecular Features Associated with Vascular Alterations in Aging

ABSTRACT
Aging is a complex biological process that significantly impacts tissue and organ physiology, particularly the
vascular system. This decline in vascular function is a major risk factor for various chronic diseases, including
cardiovascular diseases, stroke, neurodegenerative disorders, obesity, sarcopenia, osteoarthritis, and cancer.
Endothelial cell senescence, characterized by loss of function and increased secretion of harmful factors,
contributes to vascular dysfunction. These changes are driven by processes such as inflammation, oxidative
stress, and alterations in signaling pathways, leading to molecular changes and the accumulation of senescent
endothelial cells. Detecting these changes involves assessing differential expression and localization of
extracellular proteins in vascular endothelial cells (VECs), which are crucial in age-related vascular dysfunctions.
To enhance our understanding of these molecular mechanisms and age-related pathologies, innovative
techniques for imaging molecular and cellular alterations are needed. In vivo phage display has translational
potential for identifying aging markers and VEC targeting ligands. Our team has successfully identified peptide
ligands for various biological processes, including cancer, obesity, atherosclerosis, trauma, and retinopathy. In
this proposal, we aim to isolate and characterize peptide ligands targeting VECs in young versus aged mice in
vivo and senescent versus non-senescent murine VECs in vitro. Our preliminary data from aged mice tissues
reveal thousands of shared and tissue-specific peptide ligands. Aim 1 involves additional biopanning in young
mice for comparison with aged animal peptides. Aim 2 focuses on identifying peptide ligands specific to
senescent VEC receptors through further biopanning. Aim 3 aims to validate the specificity of promising peptide
ligands in cells and tissues, identifying their receptors and evaluating their expression in aged tissues.
Completing these aims will provide an innovative approach to study vascular aging, potentially paving the way
for senolytic drug development or targeting strategies for age-related vascular dysfunction-related diseases.

Public health relevance
NARRATIVE Aging exerts a profound impact on the vasculature, contributing to various pathologies; however, the molecular events underlying vascular aging and physiological decline remain poorly understood. In this proposal, we will apply an innovative approach of phage display screening in aging to identify ligands that recognize receptors that exhibit differential regulation or accessibility during vascular aging. These studies hold the promise for a comprehensive understanding of the molecular landscape of vascular aging and advancing the translational potential as diagnostic and therapeutic targets.